Mechanistic studies of the NRF2-Methylosome interaction in lung cancer.

ABSTRACT
Lung cancer (LC) is the leading cause of cancer death, making up nearly 25% of all cancer deaths. Although
some advances in personalized treatments have improved survival rates, there is an ongoing clinical need to
develop novel targeted therapies against LC subtypes with particularly poor prognosis. However, our ability to
develop these treatments is currently limited by a lack of compelling actionable targets. Publicly available
screening data, along with a multitude of prior studies, have validated nuclear factor erythroid 2-related factor 2
(NRF2) as a strong and selective dependency in lung cancer. According to patient data, it is estimated that 15%
to 30% of LC tumors have loss of function mutations in either NRF2 or KEAP1, and these mutations are
associated with resistance to conventional treatments and poor prognosis. Furthermore, despite its importance
in sustaining tumor growth, germline NRF2 knockout mouse models produce generally normal mice with no
significant developmental or health-related issues. Combined, these results suggest NRF2 has a wide
therapeutic index and merits further investigation as a potential drug target for LC. Therefore, the proposed
research explores the potential for NRF2 to be a novel therapeutic target in lung cancer by biochemically
characterizing its functional binding partners. To overcome the inherent challenges of targeting NRF2, we used
a high-throughput reporter screen and biochemical assays to identify PRMT5 as a putative modulator of NRF2
activity. We hypothesize that the activity of NRF2 in KEAP1-mutant LC is negatively regulated by a PRMT5-
NRF2 interaction, and that loss of this interaction leads to intolerable levels of NRF2 activity that promote tumor
growth. This hypothesis will be addressed by mapping the biochemical interaction between PRMT and NRF2
(Aim 1), characterizing the PRMT5-mediated repression of NRF2 transcriptional activity (Aim 2), and evaluating
the impact of methylosome perturbations on KEAP1-mutant LC growth (Aim 3). To accomplish the first aim, we
will use reconstituted NRF2 and PRMT5 to carryout advanced biochemical assays designed to identify critical
residues necessary for this interaction. For the second aim, we will employ both nascent RNA-seq and a
combination ChIP-seq analysis to uncover the mechanism of PRMT5-mediated repression of NRF2 activity.
Finally, using available small molecule inhibitors we will assess how disruption of the PRMT5-NRF2 interaction
influences tumor growth in KEAP1-mutant LCs. The information gained from this project will provide a solid
foundation for the advancement of future drug development efforts focused on targeting NRF2.

Public health relevance
NARRATIVE: Lung cancer is the leading cause of cancer deaths in the world, and while treatment options have improved, there remains a tremendous need for targeted therapies to improve lung cancer survival rates. Our lab has recently identified PRMT5 as a putative modulator of NRF2, an oncogenic transcription factor that is selectively essential in lung cancers, which could serve as a more tractable target for the development of novel therapies. This project will combine biochemical and functional genomic approaches to determine the molecular mechanisms that link NRF2 and PRMT5 and assess its potential as a target for novel cancer targeted therapies.